DATA MANAGEMENT AND STATISTICS CORE

The role of the Data Management and Statistics Core will be to facilitate research through the University of Pittsburgh Alzheimer's Disease Research Center by providing high quality data management and study methodologic support. Specifically, the aims of this Core will be: 1. Provide efficient database management systems to ensure complete and accurate research data 2. Collaborate with NACC and NIA initiatives to contribute to national databases 3. Provide computerized systems to support processes integral to the operations of the ADRC 4. Provide methodological and analytical support to ADRC researchers.

Public health relevance
The data collected in the various projects and Cores of the ADRC require central management to maximize their utility for scientific investigations. A Core with personnel having the expertise to effectively and efficiently create complete and accurate computerized databases is essential to the scientific mission of the ADRC, including the ability to share data with approved investigators locally, nationally, and internationally.